Adipocytes and Botanicals/Jacequeline M. Stephens

In preliminary studies we have identified botanicals that have favorable (selected Artemisia species) and unfavorable (St. John's Wort) effects on adipocyte development and function. The overall goal of project 2 is to study these specific botanicals to investigate the cellular mechanisms by which these botanicals regulate adipocyte function and influence whole body, insulin action. This goal is in harmony with the overall goal ofthe Center to provide a comprehensive evaluation of botanicals in addressing the pathophysiologic mechanisms that lead to the development of insulin resistance and the metabolic syndrome. Our studies will focus on adipocj/te development, adipokines, and insulin action. We will also fulfill the aims ofthe center by continuing active collaborations with project leaders and core participants. Additionally, we will perform studies to identify the bioactive constituents of Artemisia and SJW extracts, and to elucidate how these compounds effect adipocyte development and insulin action.

Public health relevance
Significant advances towards understanding obesity, diabetes, and metabolic syndrome have been made by studying adipocyte development and fat cell function. Our studies focus on understanding the contribution of botanicals that negatively and positively affect adipocyte function. These studies will provide information of public health importance.